Improving the Efficiency and Efficacy in Authoring Essential Clinical FAQs

DESCRIPTION (provided by applicant): Research plan: The use of clinical knowledge systems such as UpToDate that provide reliable information at the point of care has been shown to improve patient safety and decision-making. With similar content to UpToDate, Mayo Clinic's AskMayoExpert (AME) is an online knowledge system that primarily contains over 5000 (and increasing) specialist-vetted answers to FAQs for point of care use. However, because of the overabundance of clinical resources and guidelines, adding new answers manually to AME and ensuring that it is consistent with evidence is time consuming. This problem is also faced with other systems such as UpToDate. This career grant proposes to investigate the feasibility of using a novel text mining based informatics approach to semi-automate the management of a clinical knowledge system, using AME as the test bed. Although the methods will be applicable to any clinical knowledge system and any topic, they will be evaluated using two important test topics from cardiology (which has the biggest focus in AME) - atrial fibrillation (a topic exhaustively covered in AME) and congestive heart failure (a topic less covered, but is an increasingly complex vast field with knowledge from huge literature). While the existing content of AME is private, the methods and the code we develop to assist in generating the content will be released open-source as part of the Open Health Natural Language Processing (OHNLP) consortium in UIMA framework. Career plan: As most communication of information in clinical practice and biomedical research occurs through the medium of text, the development of methods to render this text computer-interpretable is a prerequisite to the use of this information to improve quality of care and support scientific discovery. The PI's long-term career goal is to become a leader in biomedical informatics (informatics applied to biomedical data), with focus on textual data such as scientific papers and clinical notes. He has BS in Computer Science, PhD in Biomedical Informatics and over a dozen of peer-reviewed publications in biomedical text mining. His career goal is to advance diverse methods and applications of text mining across biomedical informatics (BMI). He will focus on: a) discovering information needs and gaps that can be filled, b) adapting and extending existing text mining algorithms, and c) validating the utility of the applications in the biomedical environment. Rationale: Making the transition from a mentored researcher to an independent researcher requires three main facets of career growth: a) developing a working familiarity with clinical information systems and medical terminologies; b) understanding the information needs of clinicians; and c) training in clinical research. The proposal will translate the PI's knowledgeof the text mining methods to practical experience in an operation clinical environment. Courses listed in the Career Development/Training Activities will educate him more about the environment and train him on clinical research. He will continue sharpening his informatics expertise by attending scientific conferences.

Public health relevance
Project Narrative Medical errors are one of the leading causes of death in the United States. It has been observed that point of care access to relevant clinical knowledge support decision making and decreases medical errors, thereby improving patient safety and healthcare costs. The proposed research aims to empower physicians specialized in the area (specialists) in quickly gathering evidence from literature or finding citations supporting or qualifying their expert opinion. It will also generate the answers and suggest updates to the existing answers for their perusal. __SpecificAimsTextDelimiter__ SPECIFIC AIMS {The use of clinical knowledge systems such as UpToDate that provide reliable information at the point of care has been shown to improve patient safety and decision-making. With similar content to UpToDate, Mayo Clinic's AskMayoExpert (AME) is an online knowledge system that primarily contains over 5000 (and increasing) specialist-vetted answers to FAQs for point of care use. 92% of the generalists and around 60% of the other physicians, residents and nurses at Mayo Clinic use AME. However, because of the overabundance of clinical resources and guidelines, adding new answers manually to AME and ensuring that it is consistent with evidence is time consuming. This problem is also faced with other systems such as UpToDate. The PI's long-term career goal is to become a leader in biomedical informatics (informatics applied to biomedical data), with focus on textual data such as scientific papers and clinical notes. He has BS in Computer Science, PhD in Biomedical Informatics and publications in biomedical text mining. This career grant proposes to investigate the feasibility of using a novel text mining based informatics approach to semi- automate the management of a clinical knowledge system, using AME as the test bed. Although the methods will be applicable to any clinical knowledge system and any topic, they will be evaluated using two important test topics from cardiology (which has the biggest focus in AME) - atrial fibrillation (a topic exhaustively covered in AME) and congestive heart failure (a topic less covered, but is an increasingly complex vast field with knowledge from huge literature). While the existing content of AME is private, the methods and the code we develop to assist in generating the content will be released open-source as part of the Open Health Natural Language Processing (OHNLP) consortium in UIMA framework. The specific aims of this work are: AIM 1: Prioritize knowledge sources essentially relevant to a clinical topic using EHR (K99). The vocabulary used in AME or UpToDate is similar to that of clinical notes. In contrary, the usage of terms and their respective frequency is vastly different between literature and clinical notes. We will use term distribution statistics derived from clinical notes to prioritize the journals and organization publications that uses the same language as the notes in a topic. AIM 2: Retrieve citations for the specialist's answers (K99). While the answers written by specialists for AME are useful for quickly addressing clinician information needs at the point of care, there is a need to link these answers with evidence from literature. A user-guidable information retrieval system will suggest documents related to the answers (and questions for AIM 3) from published medical evidence from the sources prioritized in AIM 1 based on semantic similarity, importance of the citation and prominence of the author(s). AIM 3: Gather new answers and update the existing ones (R00). Currently, specialists first draft answers to the topics assigned and later review the answers after a handful of related literature for the whole topic are returned by the support staff. The workflow would be more effective and efficient if there is a way to first prepare the answers based on evidence with inline citations and then the specialists edit them and add new content (with citations retrieved using AIM 2 methods). A system summarizing documents relevant to the question will automatically gather pertinent answer in such a fashion. An extension of this system will gather information from literature that contradicts existing answer. AIM 4: Implement and validate the framework in real environment (R00). The main hypothesis is that by using the methods proposed above the specialist physicians will yield a) higher proportion of answers that are cited with evidence and b) indicate a reduced workload than when using a traditional (human only) workflow, and c) the machine-generated answers will be useful without their curation for general clinicians. AIM 4 will first implement a user-interface for the methods delivered by AIMs 2 and 3 with the help of Mayo Clinic's usability lab. A group of cardiologists will participate in separate randomized crossover studies to test the overall hypothesis. The 25 FAQS in the two test topics will be used for the validation. AIMs 1 and 2 of the proposal facilitate the PI to gain experience with electronic health records and clinical decision support systems, respectively. AIM 3 is a challenging objective that allows him to apply his expertise in biomedical text mining for supporting clinical decision-making. AIM 4 prepares him to make independent scientific contributions to the use of informatics for healthcare. It is highly likely this proposal makes the AME's workflow more efficient and evidence-based in a way that the knowledge curation methods proposed are generalizable to other systems such as UpToDate. Since the methods could also validate the feasibility of seamlessly integrating literature-based evidence into clinical decision support systems, it might be the stepping-stone for his future goal to connect electronic health records with contextual summaries generated from literature at the point of care.}